Generation of tumor specific immunity in canine osteosarcoma through dendritic cell hyperactivation

PROJECT SUMMARY
Despite substantial improvements in therapeutic strategies, generating robust anti-tumor immune responses in
human cancers with a lower somatic mutation burden remains a substantial challenge. Recent data indicate that
a critical player in this process, dendritic cells (DCs), fail to effectively elicit efficient and durable T cell responses
unless they have entered a unique state of hyperactivation. In this setting, DCs exhibit enhanced migration to
local lymph nodes (LNs) and sustained secretion of IL-1β, a cytokine critical for memory T cell formation. In
mouse tumor models, vaccination with whole tumor lysate plus an adjuvant consisting of the TLR 7/8 agonist
R848 (resiquimod) in combination with a unique isolated lysophosphatidylcholine (22:0 Lyso PC) promotes DC
hyperactivation, expansion of antigen specific CD8+ T cells, and robust rejection of tumors. While these findings
are encouraging and suggest that identification of specific neoantigens is not necessary to prime and expand a
pool of cytotoxic T cells (CTLs), validation and optimization of this approach necessitates the use of a model
system that more closely recapitulates human cancers with respect to immune landscape. As such, the purpose
of this proposal is to use spontaneous canine cancer, specifically osteosarcoma (OS), as a bridging
animal model to validate the utility of DC hyperactivation as a foundational element for generation of
robust anti-tumor immunity. The central hypothesis to be tested in this application is that combining
hyperactivation of DCs with WTL derived neoantigen will expand a diverse and tumor-specific population of CTLs
capable of eliminating residual microscopic metastatic OS tumor cells in dogs following primary tumor removal
(amputation). We further predict, that combining DC hyperactivation/WTL with a novel tumor microenvironment
(TME) conditioning regimen consisting of toceranib/losartan/ladarixin will enhance the objective response rate
in dogs that develop macroscopic lung metastasis. To accomplish this, we will conduct a prospective randomized
clinical trial in dogs with OS combining amputation and standard of care carboplatin chemotherapy with adjuvant
alone or adjuvant+WTL. Dogs that develop lung metastasis will then be treated with the TME conditioning
regimen in combination with adjuvant+WTL. A biobank of tissue samples and blood will be collected from dogs
enrolled in these trials including matched primary/metastatic tumors and associated LNs, whole blood, plasma,
PBMCs, cell-free DNA, and samples from the vaccine draining LNs. These will be used to perform a set of
complementary assays designed to characterize the immune microenvironment and tumor genome over the
course of relapse/resistance, credential a novel neoantigen prediction pipeline, and evaluate antigen specific T
cell responses. An outstanding team with complementary sets of expertise across clinical trials, translational
oncology, comparative genomics, and immuno-oncology has been assembled to ensure stated milestones are
achieved. This is bolstered by a dynamic collaboration with our industry partner, Corner Therapeutics, which is
committed to supporting this work to facilitate optimization and successful translation into human patients.

Public health relevance
PROJECT NARRATIVE Recent data indicate that effective and durable immune responses are optimally generated when key antigen presenting cells (dendritic cells, DCs) enter a state of hyperactivation during which they exhibit enhanced functional capacities including robust migration to local lymph glands and sustained production of key cytokines. In mouse models of cancer, DC hyperactivation combined with lysate derived from tumors induces durable anti- tumor immune responses, even in the setting of resistance to classic immunotherapies such as checkpoint inhibitors. The studies in this proposal will use spontaneous canine osteosarcoma as a bridging animal model to credential and optimize a novel vaccine platform designed to induce hyperactivation of DCs in vivo, complete a series of tumor and immune biomarker analyses to dissect correlates of response to treatment, and create a blueprint for application of this new approach to human patients with osteosarcoma.